Engineering alternative splicing programs to accelerate maturation of stemcell-derived neurons

Engineering alternative splicing programs to accelerate maturation of stem cell-derived neurons
PROJECT SUMMARY
Incurable aging-related neurodegenerative diseases are a growing public health crisis. The ability to generate
substantial quantities of disease-pertinent neuronal types, with and without predisposing mutations, holds great
promise for probing disease mechanisms and developing therapies. However, while tremendous progress has
made it possible to differentiate pluripotent stem cells to neurons of various developmental lineages, current
protocols yield neurons that fail to mature in vitro and stall at an embryonic identity. This reflects a fundamental
gap in knowledge concerning the underlying molecular programs that drive neuronal maturation and aging,
limiting the potential of stem-cell-based interrogations of late-onset diseases. This study aims to address this
critical conceptual and technological challenge. The mammalian nervous system employs alternative splicing to
massively expand the complexity of genetic information encoded in the genome. Our recent studies on
developmental alternative splicing programs revealed that thousands of alternative exons show dramatic splicing
switches at precise time points during neuronal maturation; these switches lead to expression of adult transcript
and protein isoforms involved in morphological and functional maturation of neurons. Importantly, we identified
core RNA-binding protein (RBP) splicing factors, whose expression is developmentally regulated to drive the
coordinated maturation-dependent splicing changes. These discoveries have led us to hypothesize that
engineering alternative splicing programs by manipulating the expression of key splicing factors in nascent
neurons will be sufficient to overcome gene regulatory barriers and accelerate neuronal maturation at the
molecular, cellular and functional levels, in a similar way that ectopic expression of Yamanaka factors
reprograms somatic cells to pluripotent stem cells. In this study, we will combine the strengths of Wichterle lab
in spinal motor neuron development and Zhang lab in systems RNA biology to test this hypothesis by focusing
on stem cell-derived spinal motor neuron as a model. We will test different combinations of candidate RBPs,
timing and duration of heterochronic RBP expression to find the optimal experimental condition that can
effectively activate the mature splicing programs. Systematic evaluations will be performed to assess molecular,
morphological, and electrophysiological maturation of the reprogrammed cells. If successful, this project will
develop a platform technology with a broad impact on studies of the adult and aging nervous system in health
and disease.

Public health relevance
PROJECT NARRATIVE This proposal aims to develop technologies to produce mature neurons differentiated from pluripotent stem cells. The proposed studies will particularly focus on spinal motor neurons, which are selectively affected in multiple devastating late-onset neurodegenerative diseases including ALS. The resulting platform technologies can lead to improved disease models to better understand etiopathological mechanisms and develop potential therapeutics.